Training Grant in Cellular, Biochemical and Molecular Sciences

Project Summary/Abstract
This application requests support for a predoctoral Training Program in Cellular, Biochemical and
Molecular Sciences (CBMS) at Thomas Jefferson University. We request 5 years of funding to
support training in the use of biochemical, cellular and molecular strategies to address important
biological questions. The program combines didactic coursework to lay conceptual foundations,
seminar and small group courses and meetings to enhance scientific communication, rigorous,
evidence-based, research training with a diverse array of mentors to enhance critical thinking
skills, and career development activities to provide information and access to a broad set of
biomedical research careers. All mentors in this program have established research programs
and significant experience in mentoring. The program will be evaluated through both internal and
external review mechanisms to ensure that the trainees receive the best possible training
experience.
The CBMS Training Program includes faculty research mentors from 10 basic and clinical
departments (Biochemistry & Molecular Biology, Cancer Biology, Medical Oncology, Medicine,
Dermatology & Cutaneous Biology, Microbiology & Immunology, Neuroscience, Orthopedic
Surgery, Pathology, Anatomy & Cell Biology, and Pharmacology & Experimental Therapeutics)
and is administered by the Principal Investigators and Administrative Committees. The CBMS
Training Program is focused on delivering broad, cross-disciplinary training in the molecular
regulation of cellular function and dysfunction in a safe, diverse, and inclusive environment to
produce scientists with strong expertise in critical scientific reasoning, rigorous and reproducible
experimental design, quantitative approaches, and excellence in data analysis and interpretation.
Overall, the CBMS Training Program will provide outstanding cross-disciplinary predoctoral
training in the use of mechanistic approaches to address important scientific questions in health
and disease. Career development programs and plans to enhance diversity within the biomedical
research workforce will not only enhance the CBMS Training Program but will enrich and elevate
the overall predoctoral training environment at Thomas Jefferson University.

Public health relevance
Project Narrative The overall goal of this training program is to develop highly trained research scientists who understand how to address important scientific questions and are ready to pursue diverse biomedical careers that support the NIH mission. The program also provides trainees with an understanding of the mechanisms involved in health and disease, giving our training program high relevance to public health.